Regulation of Intraocular Pressure via a Novel Adjustable Glaucoma Drainage Device

Project Summary
The proposed project aims at studying regulation of aqueous outflow for controlling intraocular pressure
(IOP) of eyes by developing a novel adjustable glaucoma drainage device (AGDD). The proposed function of
controlling IOP is empowered by a magnetic shape memory polymer (SMP) composite (M-SMP-C) valve that is
integrated within a conventional shunt silicone tube. The shape of the M-SMP-C valve can be reprogrammed on
demand by external magnetic fields, thus modulating the flow resistance of aqueous humor from the anterior
chamber of the eye into the subconjunctival space outside of the wall of the eye. The modulation is continuous,
postoperative, and non-invasive. To achieve the goal, recent development of novel responsive materials in the
PI’s group will be leveraged to develop M-SMP-C consisting of a poly(glycerol-dodecanoate) acrylate (PGDA)
and polyacrylic acid (PAA) (PGDA-PAA) shape memory elastomer which has a programmed shape change at
41 ℃ and two magnetic microparticles: neodymium–iron–boron (NdFeB) and Fe3O4. The preliminary results
show that the proposed material has great biocompatibility, chemical stability, and mechanical properties.
This project will be carried out to validate two hypotheses: 1) the fabricated M-SMP-C valve will show
desired shapes under the magnetic fields through material and structure design; 2) shape reprogramming and
deployment of the valve integrated in the AGDD will result in regulation of aqueous flow for IOP control. First,
we will design and synthesize M-SMP-C followed by material characterizations of their microstructures to
correlate the structures with the magnetic-mechanic response properties. Then the fabricated M-SMP-C valves
will be integrated with a shunt tube to make an AGDD for in vitro study. The flow characteristics across the
fabricated AGDDs will be studied and compared with the results from a computational fluid dynamic study. In
turn, these results will serve as feedback to improve the material design and device fabrication. Finally, we will
evaluate the material biocompatibility and device performance via ex vivo and in vivo studies.
If successful, this proposed technology will show unprecedented advancement to address the long-standing
issues inherited in conventional GDDs for IOP management. First, a surgical option will be developed to treat
glaucoma by the proposed AGDDs which can be postoperatively and non-invasively adjusted on demand. This
technology will address the clinical need despite the evolution of traditional GDDs in the past 50 years and the
recent advent of minimally invasive glaucoma surgery (MIGS) shunting technologies. Second, capability of
continuous and reversible valve adjustment will eliminate an otherwise tenuous and challenging postoperative
course, thus obviating the need for reoperations and post-hoc modifications of available GDDs. Third, the
proposed AGDD is compact and shows a similar structural form to a conventional GDD, thus will be familiar to
the surgeons. In summary, this technology would represent a paradigm shift in the surgical management of
glaucoma, helping to preserve the vision of millions of patients affected by this disease.

Public health relevance
Project Narrative The proposed project aims at studying regulation of aqueous outflow for controlling intraocular pressure (IOP) of eyes by developing a novel adjustable glaucoma drainage device (AGDD). If successful, it will show unprecedented advancement in addressing the long-standing issues inherited in the conventional GDD implants including high failure rates and many post-surgery complications. Thus, the technology would represent a paradigm shift in the surgical management of glaucoma, helping to preserve the vision of millions of patients affected by this otherwise blinding disease.